Live Cell Imaging System for Biomechanics and Mechanobiology Research

Project Summary
The goal of this proposal is to acquire a Zeiss Axio Observer 7 Live Cell Imaging system which will be coupled
with available custom-made and commercial bioreactor systems that will enable biomedical research focused
on deformation microscopy, mechano-adaptation and cell tracking approaches for researchers at Boise State as
well as neighboring and collaborator institutions. Led by NIH initiatives Center of Biomedical Research
Excellence (COBRE) at Matrix Biology and Idaho Network of Biomedical Research Excellence (INBRE) there
was a rapid growth of biomedical research focused at biomechanics and mechanobiology in Boise State. These
efforts are further supported by both new PhD programs like Biomedical Engineering and by established PhD
programs such Materials Engineering and Biomolecular Sciences that seen increased Bioengineering focus over
the years. Despite this growth, there is only one confocal microscope to serve all the researchers in Boise State.
This not only bottlenecks the use of confocal system which is better suited for 3D applications, but also limits
mechanistic approaches to study how extracellular cues regulate function of living cells. The Axio Observer 7
with mechanobiology apabilities is a critical instrument for a diverse and growing number of biomedical
researchers at Boise State University. These researchers include biomedical engineers, biomechanists, and
biologists from three colleges: College of Engineering, College of Health Sciences, and College of Arts and
Sciences. A unifying theme of this group’s research is the investigation of mechanically active musculoskeletal
systems and materials in normal, diseased, and treated states. With strategic investments by Boise State
University, this group has rapidly grown in the last 10 years (7 new faculty, 5 new labs), creating a critical mass
of complementary expertise that is positioned to collaborate on transformative and synergistic orthopaedic and
musculoskeletal research. Yet achieving this potential requires the acquisition of state-of-the-art equipment to
investigate the physiological and pathophysiological processes from molecular to tissue scales. Our ability to link
this structural hierarchy is currently limited by the absence of a system that can apply physiologically relevant
forces with a capability to observe molecular and mechanical consequences. As a result, biomedical faculty at
Boise State University are poorly equipped to transition from discoveries in basic science to innovations with
direct clinical application related to musculoskeletal health. Therefore there is a clear benefit of this live-cell
imaging and mechanosignaling capabilities offered by this microscope system. The acquisition of the Axio
Observer 7 with mechanobiology capabilities will correct this deficiency and will not only benefit NIH funded
current project but also spur the initiation of many impactful projects with high funding potential.

Public health relevance
Project Narrative This equipment is designed to examine structure and function of live cells under external mechanical stimuli. Understanding how signals associated with physiological force regulate cellular function is of paramount interest for potential therapeutic interventions and poised to lay the foundation for novel advances in treatment and prevention of musculoskeletal decline as seen in cancer, aging, obesity, bedrest and other musculoskeletal conditions.